High-Throughput NMJ Assay for Botox Potency Screening

PROJECT SUMMARY
The Botulinum Toxin Potency Assay using Tissue Chips program from FDA and NCATS highlights the need for
novel engineered systems capable of reliably evaluating botulinum toxin (BoT) potency. Human induced
pluripotent stem cell (iPSC)-derived motor neurons and muscle cells have been previously maintained in co-
culture and shown to form functional synaptic contacts representing in vivo neuromuscular junctions (NMJs).
However, the ability to effectively model NMJ functional responses to BoT using in vitro platforms amenable to
high-throughput screening has yet to be achieved due to the complexity of generating mature and functionally
competent NMJs in culture. The development of a high-throughput platform capable of promoting NMJ
development across a multiplexed assay will have a substantial positive impact on BoT production, as well as
advanced therapy development, drug efficacy/toxicity screening, and mechanistic studies of neuronal and NMJ
pathophysiology in neurodegenerative diseases. Based on preliminary work and published data, we posit that a
culture platform integrating electrode-based stimulation of neuronal firing and magnet-based measurement of
engineered muscle contraction will enable real-time analysis of NMJ development and function at baseline and
in response to BoT exposure. Using iPSC-derived motor neurons and muscle cells, we will establish organized
co-cultures within a culture plate that is compatible with our company’s existing muscle contractility assay,
MantarrayTM. Microchannels in the walls separating the cells will allow neuronal processes to grow into the
muscle compartment, facilitating synaptic contact. Tests with reference batches of BoT, in terms of their ability
to alter synaptic communication between our cell populations, will then be used to demonstrate the suitability of
this model for assaying NMJ function and BoT potency in vitro (Phase 1). Once validated, our NMJ assay will be
further evaluated to determine its accuracy, precision, specificity, and reproducibility in modeling BoT responses
in human tissues (Phase 2). Reference batches of BoT will be tested across a wide range of donor cell sources
and in comparison to an array of reference compounds with known and predictable effects on NMJ function. The
central hypothesis of this work is that differences in NMJ function between engineered skeletal muscle and motor
neuron co-cultures treated with different doses of BoT will enable stratification of phenotypes that can be
successfully used to plot dose response curves comparable to output data from mouse lethality bioassays (the
current gold standard for BoT potency screening). Successful completion of this study will provide a new
prototype human-based platform for modeling human peripheral neuropathies as well as a valuable preclinical
screening tool for assessing novel therapeutics. The consumable plate will be integrated with Curi’s existing
hardware/software packages and so can be quickly disseminated to customers upon validation.

Public health relevance
PROJECT NARRATIVE Current approaches to measuring the potency of manufactured lots of Botulinum toxin (BoT) involve laborious and ethically dubious mouse lethality assays. Organ on chip technologies based on human induced pluripotent stem cells offer an attractive solution as they can be performed rapidly and in absence of ethical concerns. In this proposal, we will develop an integrated, next-generation platform consisting of instrumentation and stem- cell based models of the neuromuscular junction that can be used for BoT potency assays.